Mechanism and Role of Membrane Fusion by the Atlastin GTPase - Equipment Supplement

Membrane fusion is fundamental to biology. Studies on viral and SNARE fusion protein catalysts have revealed
a common strategy by which proteins anchored in opposing membranes undergo favorable protein-folding
reactions that draw the membranes into close apposition and drive the lipid rearrangements necessary for fusion.
More recently, a new fusion paradigm has arisen with discovery that atlastin (ATL) a membrane-anchored
dynamin related GTPase can trigger fusion of synthetic vesicles and is required for the branched morphology of
the ER. ATL is distinct from previously studied fusion proteins because it couples fusion catalysis to the
hydrolysis of GTP. Importantly, while substantial progress has been made on the ATL fusion mechanism, a
consensus has yet to be reached. In the presence of GTP, the N-terminal cytosolic domain of ATL undergoes
trans dimerization through the GTPase domain and a crossover conformational change hypothesized to draw
membranes sufficiently close together to drive fusion. However, no fusion is observed in the absence of an
amphipathic helix within the C-terminal cytosolic tail of ATL, suggesting a sequential model in which crossover
formation constitutes an upstream step for membrane docking, and the tail functions subsequently to drive lipid
mixing. On the other hand, our recent work suggests that crossover dimerization provides the energy for fusion
but does not explain the role of the tail. Thus, whether crossover serves primarily to mediate docking, or whether
it drives fusion, needs to be resolved. Similarly, how GTP hydrolysis energizes the fusion reaction cycle remains
under debate. Prevailing models have held that the hydrolysis of GTP powers formation of the ATL crossover
dimer directly for fusion. However, our recent work suggests that GTP hydrolysis serves to disassemble the
crossover dimer after fusion for the purpose of subunit recycling. In aim 1, we will use FRET probes to distinguish
whether crossover dimerization can be uncoupled from fusion, or whether it plays a central role and therefore is
inseparable from fusion. In aim 2, we will extend our analysis of the GTP hydrolysis reaction cycle from the
soluble phase to the context of membranes to ascertain whether the hydrolysis of GTP, as suggested by our
recent work, functions only after the completion of fusion for the purpose of subunit recycling. Finally, previous
studies on the ATL fusion mechanism have relied on use of the Drosophila ATL ortholog, the only ATL for which
in vitro reconstitution of fusion activity has been achieved. This has limited our understanding of the role and
potential regulation of the multiple ATL paralogs ATL1-3 present in humans. Thus, a third major goal is to
reconstitute the fusion activity of the human paralogs. Altogether, the proposed studies promise to reveal the
core principles of how GTP-dependent fusion proteins catalyze membrane fusion and to reveal sorely lacking
insights into the mammalian ATL1-3 paralogs. Because mutations in human ATL1 cause the motor neurological
disorder HSP whose basis is not understood, these studies have the potential to shed light on disease causality
and possibly also impact its therapeutics.

Public health relevance
The proposed studies seek to use biochemical, biophysical, and cell-based approaches to better understand the molecular mechanism by which the atlastin GTPase harnesses nucleotide hydrolysis to catalyze the fundamental process of ER membrane fusion. Mutations in atlastin1 cause the human motor neurological disorder hereditary spastic paraplegia (HSP). Therefore, the outcomes will not only to provide insights into the principles by which a mechanochemical enzyme catalyzes membrane fusion but will also reveal new information on the basis for HSP.